ANALYSIS OF CW EPR OF HEMOPROTEINS

Continuous wave EPR spectroscopy was used to identify radicals formed during oxygen inactivation of the enzyme, pyruvate formate lyase. Evidence was found for formation of a sulfinyl radical on cysteine in the wild-type enzyme, and in mutant C418A while an alkyl